Using artificially intelligent text messaging technology to improve American Heart Association's Life's Simple 7 Health Behaviors: LS7 Bot + Backup

PROJECT SUMMARY/ABSTRACT
Our goal is to improve control of cardiovascular (CV) disease risk factors using a multilevel intervention
leveraging cellphone-based text messages integrated within health systems to improve control of American
Heart Association’s Life’s Simple 7 (LS7) lifestyle factors (blood glucose, cholesterol, blood pressure, physical
activity, weight, diet, and smoking). When uncontrolled, these lifestyle factors lead to common co-existing
chronic conditions (e.g., hypertension, diabetes), morbidity, health care costs and death. Patients who
experience health disparities (i.e., ethnic minorities, those with limited English proficiency and those with low-
income) are disproportionately affected by CV diseases, have worse disease control and suffer greater
sequelae.
Self-management is an individual’s role in managing chronic disease and has strong evidence of benefit. It
includes self-care, lifestyle changes (e.g., increase physical activity), taking medications as prescribed and
managing exacerbations of chronic condition(s). Text messaging interventions have improved health behaviors
including physical activity and medication adherence. Incorporating behavioral “nudges,” defined as a small
change in choice architecture that “alters people’s behavior in a predictable way” into text messages may
further augment its impact. Behavioral nudges are more personalized, resonate better with patients, and have
changed health behaviors. However, text message interventions have typically not been delivered to large
samples, focused on patients experiencing health disparities, nor leveraged health system electronic health
record (EHR) data to personalize content and maximize scale, reach and impact of messages.
Using a patient-level randomized pragmatic trial, we will test the comparative effectiveness of 3 text messaging
delivery strategies: 1) generic text messages; 2) interactive AI chatbot text messaging leveraging evidenced-
based communication strategies with attention to patient context and sociocultural factors influencing self-
management; or 3) interactive AI chatbot text messaging plus proactive pharmacist management. We plan to
enroll 6,000 patients from clinics within 3 health systems that care for large populations experiencing health
disparities: 1) Denver Health and Hospital Authority, 2), Salud Family Health Centers and 3) STRIDE
Community Health Center. We will use health system EHR data to identify eligible patients, deliver the
intervention, and assess patient-centered outcomes. The study findings will provide evidence regarding the
best population-based strategy for universal delivery to engage all patients with health disparities in self-
management to improve the AHA’s LS7. The intervention will be delivered in real world settings to augment
routine clinical care and improve access to care. We will incorporate lessons learned from one health system
into adaptations for the other health systems in the study.

Public health relevance
PROJECT NARRATIVE Our goal is to improve control of cardiovascular (CV) disease risk factors defined by the American Heart Association’s Life’s Simple 7 (blood glucose, cholesterol, blood pressure, physical activity, weight, diet, and smoking) by engaging patients experiencing health disparities in an innovative technology-based self- management intervention with linkages to health system providers. Using a patient-level randomized pragmatic trial design, we will enroll 6,000 patients from three Federally Qualified Health Centers, Denver Health and Hospital Authority, Salud Family Health Centers, or STRIDE Community Health Center. The study findings will provide evidence regarding the best population-based strategy for universal delivery to engage all patients experiencing health disparities in self-management to improve CV disease risk factors.